Engineering locus-specific binders to DNA modifications

Project Summary
Chemical modifications to genomic DNA are ubiquitous across all kingdoms of life. They are diverse in nature
including methylation, hydroxymethylation, and formylation of nucleic acid residues. It is also increasingly clear
that these modifications have diverse regulatory roles. In eukaryotes, DNA modifications regulate gene expression,
RNA splicing, genome organization, and gene imprinting; these molecular functions also have important
downstream consequences for development, disease, and organismal interactions with environmental stimuli and
chemicals. Furthermore, with the advent of genome and epigenome editing technologies, these modifications can
bias the specificity and efficiency of molecular tools. Given the broad importance of DNA modifications, any
experimental tools that are able to control, measure, sense, or track them would have profound impacts across
biological disciplines. What is particularly needed, but not yet technologically possibly, is the ability to
simultaneously sense epigenetic modifications at specific genomic locations in living and single cells. This
capability would unlock a broad palette of new experimental approaches to reveal new insights into topics such as
gene imprinting, causation vs. correlation of epigenetic modifications, and cell and tissue stochasticity.
Furthermore, it would inform the development of new classes of affinity reagents for biochemical assays, disease
detection, and diagnostics and of genome and epigenome editing technologies that are aware of and specific
towards DNA modification state. To drive this new realm of studies, we will create the first molecular tool that
binds DNA hydroxymethylation at specific and programmable genomic loci, and provide a broadly applicable
platform for engineering many other similar molecular reagents.

Public health relevance
Project Narrative The regulatory interface between the genome and epigenome is inherently important across biological systems and disease states due to its control of gene expression, among other fundamental cellular processes. Yet because this interface is highly dynamic and varies depending on genomic locus, it is difficult to probe and control in direct ways and could have consequences for the accuracy of genome and epigenome editing. Here we propose multiple parallel approaches to engineer proteins that can bind DNA modifications in a genomic sequence-specific manner.